Novel STAT3 inhibitor for overcoming chemoresistant ovarian cancer .

Abstract/Summary
Epithelial ovarian cancer (OC) is the fifth leading cause of death in women and the most lethal gynecological
malignancy in the United States. OC is mostly diagnosed at an advanced stage. Patients undergo debulking
surgery and chemotherapy or neoadjuvant chemotherapy and interval debulking surgery. Conventional drugs
are carboplatin and paclitaxel. Despite the recent introduction of FDA-approved PARP- and VEGF-inhibitors for
OC, the vast majority of patients will experience disease recurrence that requires additional treatment and
recurrent OC is essentially incurable. New therapeutics to improve patient outcomes are needed. Transcriptional
profiles have demonstrated that the master transcriptional regulator STAT3 to be highly active in OC, determined
by increased phosphorylation in SH2-dimerization domain (pSTAT3-Y705) and induction of oncogenic factors.
Active STAT3 in metastatic and chemoresistant OC correlates with poor patient survival, and inhibiting STAT3
with shRNA, or small molecules inhibited OC progression, supporting the objective of targeting STAT3 as a
viable therapeutic strategy. Additionally, we demonstrate significant upregulation of STAT3 activity in OC cells
is strongly associated with increased platinum resistance. We hypothesize that targeting STAT3 will block
multiple oncogenic pathways and sensitize OC cells to chemotherapy. Although transcriptions factors (TF) like
STAT3 are attractive therapeutic targets, TFs are challenging to target with small molecules due to lack of clear
small molecule binding pockets, large surface areas important for protein-protein interactions and large
intrinsically disordered domains. At Altay Therapeutics, we developed a platform that enables identification of
small molecule binding pockets within intrinsically disordered domains in previously undruggable TFs, allowing
a novel approach for specific targeting of STAT3 and development of potent STAT3 inhibitors (STAT3i). Using
our platform, we identified inhibitors that reduced STAT3 DNA binding by targeting the disordered DNA binding
domain. Importantly, these STAT3i have minimal STAT1 inhibitory activity, low cytotoxicity and when used in
combination with CDDP, synergized and increased platinum sensitivity across OC cell lines. We propose three
aims based on quantitative metrics that will clearly define the top candidate(s) which inhibit STAT3 compared to
existing STAT3is and block OC progression. In Aim 1, we will determine STAT3 target gene inhibition and
measure effects on secreted inflammatory factors with Altay’s novel STAT3is. In Aim 2, we will carry out in vitro
phenotypic studies with human and transgenic mouse OC cells using STAT3is in combination with platinum
chemotherapy. In Aim 3, we will determine antitumor activity of STAT3i using OC cells in orthotopic and
intraperitoneal in vivo models alone and in combination with platinum chemotherapy. The proposed studies will
establish the potential for targeting STAT3 in treating chemoresistant OC and guide new therapeutic strategies
in this setting. We will then pursue an SBIR phase 2 grant that will include medicinal chemistry efforts and
additional animal studies and ultimately commercialization of a first-in-class STAT3 inhibitor for OC.

Public health relevance
Narrative Ovarian cancer (OC) is the fifth leading cause of death in women and the most lethal gynecological malignancy in the United States. After chemotherapy more than 85% of patients have recurrent chemoresistant disease that is incurable. Therefore, an effective treatment for chemoresistant OC represents significant unmet clinical need. We have developed a drug that can be used in combination with current FDA approved chemotherapy to reduce tumor recurrence, potentially providing a safer and more effective treatment option for patients diagnosed with ovarian cancer and addressing an unmet need in the disease.